The Jackson Laboratory Senescence Tissue Mapping Center (JAX-Sen TMC) - Admin Core

PROJECT SUMMARY/ABSTRACT ADMINISTRATIVE CORE
The objective of the Administrative Core is to provide scientific leadership and operational management of The
Jackson Laboratory (JAX) Cellular Senescence Collaborative (JAX-Sen) Tissue Mapping Center (TMC) in
support of SenNet goals to map cellular senescence and its associated secretory phenotype in healthy mouse
tissues. The Administrative (Admin) Core will provide the infrastructure to support all communication,
coordination, oversight and management functions of the proposed center through a Governing Committee
(GC) comprised of all PIs and Core Leads, an experienced Program Manager, and outside guidance from
NIH program officials as necessary. Through a thoughtful Leadership Plan, the Admin Core will provide the
overall governance of JAX-Sen that ensures robust communication within JAX-Sen and with other SenNet TMCs
(Aim 1). The Admin Core will organize and oversee regular scientific meetings to foster communication and
synergy within and across JAX-Sen, and to nurture a strong, collaborative environment across JAX-Sen’s two
project sites (The Jackson Laboratory and UConn Health), across JAX-Sen and KAPP-Sen, a SenNet-funded
human Tissue Mapping Center also based at JAX and UConn Health, and across SenNet consortium
stakeholders, namely the Technology Development Centers, other TMCs, the CODCC, the SenNet Steering
Committee, and NIH program officials. Through a Tissue Mapping Center Coordination Plan, the Admin Core
will also coordinate the development of animal cohorts, collection of mouse tissue samples, data generation,
data analysis and resource and data sharing within JAX-Sen (Aim 2). The Admin Core will provide scientific
and administrative oversight of the Biological Analysis and Data Analysis Cores. This oversight, administered
by the Program Manager, will include risk assessment and decision-making, project management, timely
preparation of reports, and data quality reviews at regularly scheduled meetings with Core Leads. Through a
Network Coordination Plan, The Admin Core will also coordinate collaboration and communication with all
members of SenNet to optimize resource sharing and contributions towards overarching programmatic goals
(Aim 3). The Admin Core will collaborate with other SenNet sites and NIH program officials to design or improve
Network operations and implement protocols. The Admin Core will work with the CODCC to optimize strategies
for data collection and analysis, and to facilitate public access to SenNet data through the CODCC. The Admin
Core will coordinate plans for collaborating with other murine and human TMCs on topics including but not limited
to SOPs, assay protocols and data analysis, and pilot projects. The Admin Core will also oversee creative,
synergy-generating collaborative activities that make use of JAX-Sen’s (and JAX’s) unique resources, expertise
and infrastructure.